Multimodality Adaptive Intervention for Post-Inpatient Hospitalization Suicide Risk Reduction

ABSTRACT
Over 48,000 Americans die by suicide each year, making suicide the 11th leading cause of death across all ages.
The highest-risk time for suicidal behavior is the three months after inpatient psychiatric hospitalization, during
which engagement with traditional outpatient care is low. Recent real-time monitoring research has revealed that
suicidal thoughts fluctuate rapidly, over hours or even minutes, highlighting the need for dynamic interventions
that adapt to time-varying changes in risk. We recently developed a just-in-time adaptive intervention (JITAI) that
promotes coping strategy use during periods of elevated suicidal thinking. Our recent micro-randomized trial
(MRT; N=71 adults hospitalized for suicide risk), showed the feasibility, acceptability, and preliminary
effectiveness of this JITAI for promoting in-the-moment coping strategy use during the four weeks after inpatient
discharge. Some patients, however, require additional interventions that explicitly target common psychological
and practical barriers to coping effectively with suicidal thoughts. Evidence-based single-session interventions
that address coping with suicidal thoughts exist and can be delivered in either clinician-delivered or self-guided
formats. In this study, we will use a hybrid experimental design that leverages both Sequential Multiple
Assignment Randomized Trial and MRT methods to build and evaluate a multimodality adaptive intervention
comprising stepped evidence-based intervention components sequenced and adapted at multiple timescales
following inpatient hospitalization. Aim 1 will compare two first-stage interventions: JITAI vs. self-monitoring alone
for four weeks after inpatient discharge. We will determine the effectiveness of the JITAI for reducing the risk of
distal outcomes (suicide attempts or emergency visits/re-hospitalizations for suicide risk) over three months and
whether the JITAI engages target mechanisms related to coping strategy use. Aim 2 will compare two second-
stage interventions for those who do not sufficiently respond to the first-stage interventions: clinician-delivered
or self-guided single-session interventions targeting individualized barriers to coping strategy use. Response
status will be assessed weekly for four weeks post-hospitalization. We will determine the effectiveness of
clinician-delivered vs. self-guided single-session interventions (delivered up to three times per participant) for
reducing the risk of distal outcomes among insufficient responders, as well as effect differences between
embedded adaptive interventions among all participants. Aim 3 will determine the within-person effects of just-
in-time messages (sent or not sent in response to each self-monitoring report of elevated suicide urge or intent)
on proximal outcomes (next-hour coping strategy use and momentary suicidal thoughts) for participants in the
JITAI condition. Just-in-time message effects will be evaluated when averaging across second-stage conditions
and contrasting message types (personalized coping strategies drawn from each individual’s safety plan vs.
general recommendations) and single-session interventions (clinician-delivered vs. self-guided). This study will
result in a scalable and optimized stepped approach to reducing suicide risk during a key care transition period.

Public health relevance
PROJECT NARRATIVE The period after inpatient psychiatric hospitalization is an extremely high-risk time for suicide. In this project, we build and test an innovative, technology-assisted intervention package for the four weeks after hospital discharge that is designed to both provide support during specific moments of intense suicidal thoughts and adapt to each individual’s changing needs. We will determine the optimal combination and order of evidence-based self-guided and clinician-delivered intervention strategies during the critical post-hospitalization period.